Determining cell- and spatially-distinct skeletal muscle transcriptional aberrations in insulin resistance and type 2 diabetes

PROJECT SUMMARY
Type 2 Diabetes (T2D) is estimated to affect 30 million U.S. adults and skeletal muscle (SkM) insulin resistance
(IR) is considered to be one of the primary aberrations. Effective insulin-stimulated SkM glucose uptake is
dependent on 1) insulin-stimulated activation of terminal arteriole endothelial cells (EC) to perfuse microvascular
units, 2) transport of substrates across capillary ECs and 3) stimulation of myofiber insulin signaling, resulting in
glucose uptake. Therefore, both myofibers and ECs are critical cell types that can be dysregulated with IR in
T2D. Previous research has identified a dysregulated transcriptional profile with SkM IR in the basal state and
during insulin stimulation from a hyperinsulinemic euglycemic clamp (HE). A significant limitation of these prior
studies is the restriction to whole SkM homogenates and therefore not identifying which cells or spatial area the
dysregulated signals originate from. We have developed a pipeline for 3’ and 5’ amplification of single cells or
nuclei from SkM using full-length SMART-Seq technology with the iCELL8 platform, resulting in 2-3 fold greater
gene coverage than previous research, allowing us to investigate transcriptional aberrations at a single cell/nuclei
resolution. Recent developments in spatial transcriptomics now permit transcriptional profiling on sectioned
tissue. In this proposed research, we will leverage both full-length single cell and single nuclei RNA-Seq and
spatial transcriptomics to determine cell- and spatially-distinct transcriptional aberrations in SkM that occur with
IR in T2D. The career development training will refine my skills in; leading an independent lab, bioinformatics,
and human clinical research with a focus on assessing insulin-stimulated glucose disposal (Rd) and non-
oxidative glucose disposal (NOGD) using hyperinsulinemic euglycemic (HE) clamps with glucose tracers and
indirect calorimetry. My K99/R00 training will uniquely position me to conduct bedside-to-bench-to-bioinformatics
research to uncover the molecular profiles of SkM IR. For the first time, the transcriptional responses to insulin
in human SkM will be probed at a single cell/nuclei and spatial resolution. We will identify which cells and areas
of SkM respond to insulin and if they are spatially localized to each other and if their gene-network profiles
correlate with a greater in vivo Rd and NOGD assessed simultaneously with a HE clamp. This novel and
innovative approach will reveal which cells (and importantly, where in SkM) the aberrations occur with IR in T2D.
The Translational Research Institute at AdventHealth is an ideal environment for developing my bedside-to-
bench-to-bioinformatics research approach with cutting-edge metabolic translational research facilities and a rich
interdisciplinary environment. Completion of the proposed research and career development training will facilitate
my success as an independent translational investigator in SkM metabolism and IR. Furthermore, experiments
in this proposal will identify specific molecular targets to alleviate SkM IR that will be targeted in future grant
applications.

Public health relevance
PROJECT NARRATIVE Skeletal muscle insulin resistance is one of the contributing factors to the development of Type 2 Diabetes; however, skeletal muscle is a complex tissue comprised of multiple cell types and masses of myonuclei, making it difficult to pinpoint where these aberrations occur. This project aims to uncover which cells and which areas of skeletal muscle are dysregulated in skeletal muscle insulin resistance in Type 2 Diabetes. This information will be used to design therapeutic interventions to alleviate skeletal muscle insulin resistance.